CORE--BIOSTATISTICS AND DATA COORDINATION

Description (provided by applicant): Core D will oversee and facilitate the non-technical aspects of the grant, maintain quality control within the program and maximize an efficient execution on all aspects of program aims. It will provide the resources that are required for the overall supervision of the program, fiscal management, administrative support and other assistance as needed for project leaders and project staff. These functions will include attention to scientific timelines for the program and each of its projects and coordinating results among our investigators. General administration, consisting of correspondence with federal grants management officials, maintenance of records, and establishment of regular project meetings and related seminars will be performed by the Core Leaders and other Core personnel. This core component also includes financial administration which involves pre-award and post-award budgeting, acquisition of supplies, etc., monitoring of disbursements, grant-related payroll functions and other financial transactions. It will assure that the funds are managed in accordance with accepted federal policies and cost principles. Finally, clerical support, including typing of grant-related correspondence, manuscripts and progress reports, will be made available to all investigators through this core component.